SCI Consortium Study: 3D Printed Scaffolds for Primate Spinal Cord Injury Repair

Project Summary/Abstract
The VA provides care for approximately 26% of individuals with SCI in the U.S. Treatment costs are 6.5
times higher than the cost of treatment of an average Veteran, and effective therapies to promote recovery of
neural function are lacking. Our overarching vision is to create an ex-vivo tissue that can replace the
damaged spinal cord and enable formation of new relay circuits across sites of even severe injury. Our
extensive rodent work with 3D printed biomimetic scaffolds shows that this approach can result in
electrophysiological and functional recovery after complete spinal cord transection, the most severe model
of spinal cord injury.
This project aims to assess the efficacy of 3D printed biomimetic scaffolds, loaded with human neural
progenitor cells and implanted sub-acutely, in a long-term clinically relevant, non-human primate model of
cervical spinal cord contusion.
There are 2 objectives to this project:
1. Analysis of anatomical outcomes - Biocompatibility, integration, degradation, vascularization,
host axon regeneration into the scaffold, and neural progenitor cell-derived axon outgrowth from the
scaffold into the host.
2. Analysis of functional outcomes. Animals will be functionally assessed on tasks of right-hand
function, including Brinkman board, home cage-based robotic manipulation, forelimb and hindlimb
use in an open field/exercise enclosure, and sensation.
Successful completion of the award will provide key data to support future clinical trials, with resulting high
impact.

Public health relevance
Project Narrative The VA provides care for approximately 26% of individuals with SCI in the U.S. Treatment costs are 6.5 times higher than the cost of treatment of an average Veteran, and effective therapies for this disorder are lacking. This project aims to evaluate the efficacy of 3D printed biomimetic scaffold, loaded with human neural progenitor cells and implanted sub-acutely, in a long-term clinically relevant, non-human primate model of cervical spinal cord contusion.